Mechanisms of Cardiac Myosin Heavy Chain Gene Regulation

Project Summary
Sarcomeres are the fundamental functional unit of contractility in cardiomyocytes (and the heart) and consist of
two major contractile myofilament protein complexes: thick myosin and thin actin filaments. Myosin heavy
chain (MYH) proteins function as the molecular motors that produce sliding between these thick and thin
myofilaments, resulting in sarcomere contractility. MYH6 and MYH7 serve as the primary myosin heavy chain
proteins and are antithetically expressed at significantly different ratios according to cardiomyocyte cell type
and state (developmental and disease). Under cardiac stress and pathophysiological conditions including
heart failure, adult ventricular cardiomyocytes respond by decreasing MYH6 while increasing MYH7. Because
MYH6 displays greater ATPase activity and actin sliding velocity than MYH7, these changes in the ratio of
MYH6 to MYH7 expression can have significant effects on cardiac contractility and correlate with a decline in
cardiac performance. However, hearts expressing higher levels of MYH6 to such heart failure/cardiac stress
conditions exhibit improved responses. Thus, altering the levels of these cardiac MYH proteins can result in
significant contractility changes that can profoundly impact overall heart function. Consequently, we propose
to investigate and discover the underlying gene regulatory mechanisms that control the antithetical expression
of MYH6 and MYH7 and their isoform switching. Toward this end, a multi-disciplinary approach will be used to:
(1) investigate key cis-regulatory sequences that regulate MYH6-MYH7 promoter competition for a cardiac
MYH locus control region, (2) identify trans-acting factors that may regulate MYH6-MYH7 promoter competition
for a cardiac MYH locus control region, and (3) investigate whether altering MYH6-MYH7 gene expression can
be used to modify cardiac disease in hPSC-cardiomyopathy models.

Public health relevance
Project Narrative This proposal seeks to illuminate the gene regulatory networks controlling the antithetical expression of cardiac MYH6 and MYH7. Results from these studies will yield new insights into molecular mechanisms directing MYH isoform expression and switching under specific cardiac conditions and how they may be modified to develop new treatments for heart failure.